Identifying and Facilitating Ventricular Recovery on Mechanical Support

at the top of each printed page and each continuation page. RESEARCH GRANT TABLE OF CONTENTS Page Numbers Face Page 1 Description,